Control of Alcohol Responses by Actin-Regulating Genes

–––– PROJECT SUMMARY / ABSTRACT FOR THE DIVERSITY SUPPLEMENT –––––––––––––––––––––––––––––
Alcohol abuse disorders (AUD) are a major health hazard that affects millions of people every year in the United
States. Risk factors for AUD include initial resistance to the intoxicating effects of alcohol, as well as the
development of tolerance upon repeat exposure. AUDs also have significant genetic etiology, and many genes
have been implicated from human genome-wide association studies (GWAS), including by our studies. A
detailed molecular understanding of many of these genes is still lacking, though. “Regulation of the actin
cytoskeleton” has been implicated by numerous mammalian alcohol transcriptomics studies, and major
regulators of actin dynamics include the Rho family of GTPases, and their regulators. Our findings, supported
by prior funding periods of this competitive renewal grant, have shown that SNPs in the Rho GTPase regulator
RSU1 are associated with alcohol dependence and drinking, underscoring the translational significance of our
studies. There are several goals to this supplement application: i) in 2 scientific Aims, Pearl Cummins will
determine the role of the Rac1 GTPase regulator RhoGAP18B in ethanol-induced tolerance and investigate the
neurotransmitter systems that required RhoGAP18B for normal alcohol responses. In a second Aim, Pearl will
determine whether Drosophila can be established as a model organism to investigate the mechanisms of
hedonic tolerance. The first Aim builds on Aim1 of the parent grant and incorporates some recently generated
preliminary data. The parent grant has a focus on alcohol-induced tolerance to the sedating effects of ethanol,
as measured by a loss-of-righting assay. Since hedonic tolerance, rather than the tolerance to the motor-
incapacitating effects of alcohol, contributes to the escalation of continued alcohol intake, we need to establish
whether Drosophila can be used as a high-throughput organism to test the genetic contribution to hedonic
tolerance. Thus, Pearl's second Aim is completely novel and innovative, but logically extends from the
overarching question of the parent grant. ii) provide Pearl, who has a background in working with human subjects
during her prior research, with scientific training on genetic, molecular, and behavioral approaches in model
organisms. iii) Mentor Pearl in skills that are conducive to her career development as an independent scientist;
For latter two goals, we have developed a detailed plan for Pearl in what the experimental techniques are she
will learn and what curricular activities will expand her scientific and career skill development. Regular meeting
with the primary mentor, as well as her scientifically diverse mentoring team will provide a trove of expertise to
draw from, as well as ensure progress in Pearls scientific development; iv) enrich the workforce by integrating
Pearl, who comes from an underprivileged low-income background with no parents holding a Bachelor's degree,
in the scientific community here at the University of Utah, as well as the wider addition community.

Public health relevance
–––– PROJECT NARRATIVE (FROM PARENT GRANT) –––––––––––––––––––––––––––-––––––––––––––––––– Substance abuse disorders are a chronic human condition where initial consumption leads to long-lasting behavioral changes, driven in part by initial, and then progressive resistance to the intoxicating effects of alcohol as tolerance develops. The results of the proposed studies will provide valuable mechanistic insight into the way initial ethanol exposure causes these long-lasting behavioral changes. This will highlight novel targets for therapeutic intervention with alcohol addiction, which are largely lacking.